SBIR: In vivo engineering of multifaceted B7H3.CAR-T cells for cellular immunotherapy of pancreatic ductal adenocarcinoma

Project Summary
T-cells modified with chimeric antigen receptor against unique cancer antigens i.e., CAR-T, represent a
promising form of immunotherapy for cancer, but are currently limited by production time and costs to prepare
the engineered T-cells ex vivo, as well as by modest efficacy against solid cancers due to poor tumor
penetration. Rather than harvesting, activating, transducing, and expanding T-cells ex vivo, we believe direct
engineering of CAR-T cells in vivo, by transducing circulating T-cells with high specificity, will reduce the time
and cost of CAR-T therapy while also maximizing T-cell function by eliminating extended cultures in vitro.
Mucommune has recently in-licensed a platform that enables exceptionally potent yet highly specific
transduction of circulating T-cells, without first requiring T-cell activation, by combining both virological and
chemical approaches. Specifically, it utilizes a LV system incorporating the Nipah virus fusion protein with its
native tropism ablated and retargeted via anti-CD3 scFv, then formulates the resulting Nipah LV (NLV) with a
proprietary combo of transduction enhancers. To date, we have shown that this new system can specifically
transduce non-activated T-cells among circulating PBMCs in vivo, generate CD19-targeted CAR-T that
effectively eliminate the highly aggressive BV173 lymphoma, and generate in vivo-engineered B7-H3-targeted
CAR-T cells that eliminate metastatic non-small cell lung cancer (NSCLC) in vivo.
In this proposal, we will extend this novel NLV platform to develop more effective T cell therapy against
pancreatic ductal adenocarcinoma (PDAC). While B7-H3 is highly over-expressed in PDAC, two notable
challenges with cellular therapies against PDAC are an immunosuppressive tumor microenvironment
(iTME) and a stromal barrier that limits access of immune cells into the tumor. Dotti and colleagues recently
showed that dual IL-15+GPC3.CAR-T cells markedly improved objective response rates in patients compared
to GPC3.CAR-T, and that expression of the chemokine receptor CCR2b can greatly increase migration of
CAR-T cells into solid tumors. Thus, we believe in vivo engineered multi-functional CAR-T cells comprising
CCR2b, IL-15 and B7-H3.CAR are uniquely suited to address the challenges with PDAC. in Aim 1, we will
engineer and characterize NLVs that encode all three elements, and evaluate their transduction efficiency in
vivo as well as effectiveness in co-culture models with different PDAC cell lines and PDAC patient derived
xenografts (PDX). In Aim 2, we will assess anti-tumor efficacy, prolonged survival and reduction in
metastases of in vivo engineered CAR-T cells vs. conventional CAR-T in PDX mouse models, as well as
rigorously characterize the phenotypes of the resulting CAR-T cells. If successful, our work will likely markedly
expand the clinical adoption of CAR-T therapy, both by lowering costs but also potentially broadening their use
for treatment of solid tumors, enabling CAR-T therapy to potentially become a front-line therapy for PDAC.

Public health relevance
Narrative T cells reprogrammed to display chimeric antigen receptors (CARs) represent a promising therapeutic modality for a number of cancers, but currently suffer from high costs and modest efficacy against solid tumors. In this proposal, we seek to directly reprogram T-cells that are circulating in the blood to display CAR against the B7- H3 antigen highly overexpressed on pancreatic cancers, and evaluate the effectiveness of such CAR-T cells against pancreatic cancer in suitable mouse models. If successful, this work will advance a potentially more efficacious and cost-effective treatment for pancreatic cancer.